Training Program in Organogenesis

ABSTRACT:
The University of Michigan Training Program in Organogenesis takes advantage of the
exceptional strength and faculty expertise in developmental biology, stem cell biology and
bioengineering at The University of Michigan. This application requests funding to support 6
predoctoral trainees, and provides institutional support for two (2) additional predoctoral
candidates using a cohort model to appoint new students each year. The Training Program has
36 training faculty from diverse schools, colleges, programs and departments, and who are
uniquely suited to create a multidisciplinary training environment for our highly ambitious and
talented predoctoral trainees. The overarching goal of the University of Michigan Training
Program in Organogenesis is to provide a unique training experience that unites exciting career
and professional development activities with interdisciplinary research efforts towards
understanding how organs and tissues are formed and maintained, and how these mechanisms
are altered in disease. In the future we envision our trainees as leaders in academia and industry
who will create replacement organs, design therapeutics, improve stem cell therapies and develop
effective organ transplantation systems.
The Training Program will provide intellectual and technical training relevant to the field of
organogenesis, with a focus on understanding the mechanisms that control development or
disease pathogenesis, and how this understanding can be leveraged for organ engineering and
therapeutic strategies. It will enhance the training experience of trainees, by engaging both
faculty mentors and trainees in mentoring workshops aimed to develop a personalized and
inclusive training plan. The Training Program will serve as a point of cohesion for trainees from
diverse colleges and departments, and will promote interdisciplinary thinking by exposing
trainees to research that crosses boundaries between basic, applied, and clinical sciences. The
Program will implement several program-specific initiatives to provide trainees with unique
and tailored career development opportunities.

Public health relevance
PROJECT NARRATIVE The Training Program in Organogenesis will provide an outstanding and unique training experience that unites exciting career and professional development activities with interdisciplinary research efforts towards understanding how organs and tissues are formed and maintained, and how these mechanisms are altered in disease. Our past trainees have been highly successful, and we envision that in the future, our trainees will be leaders in academia and industry who will create replacement organs, design therapeutics, improve stem cell therapies and develop effective organ transplantation systems. Support for 6 predoctoral candidates per year is requested.